Decoding the cellular and molecular mechanisms of epileptogenesis and disease progression in mTORopathies

ABSTRACT
mTORopathies, such as focal cortical dysplasia type II (FCDII), is the most common underlying pathology in
children with drug-resistant epilepsies. However, the underlying mechanisms of epileptogenesis,
hyperexcitability, and disease progression remain largely elusive. In this proposal, we combine animal models
and resected human tissues to understand the cellular and molecular logic networks in the dysplastic cortex.
We use cutting-edge technologies in molecular genetics, electrophysiology, transgenics, and RNA sequencing
to provide conceptual insights broadly relevant to understanding mTOR-related epilepsies. Our central
hypothesis is that a sustained neurotoxic microenvironment mediated by complement component C3
progressively sculpts cellular and molecular architectures, impair cortical inhibitory circuits, and promote
epileptogenicity in the malformed cortex.

Public health relevance
NARRATIVE Dr. Yu Wang and his colleagues use both animal models and resected human tissues to study the cellular and molecular mechanisms of mTORopathies-related epilepsy (e.g., focal cortical dysplasia type II), how the overexpression of complement component C3 disrupts the balance of excitation and inhibition, and whether C3 inhibition can modify disease progression and improve seizure outcomes.